FLI1 in Pulmonary Arterial Hypertension

Pulmonary arterial hypertension (PAH) is a rare and devastating disease resulting in pulmonary arterial
remodeling, right heart failure and death. While there are FDA-approved therapies, none is curative. It has
been recognized for years that growth factors, such as platelet-derived growth factor and fibroblast growth
factor, act through tyrosine kinase receptors to promote pulmonary vascular remodeling in PAH. Imatinib, a
non-specific tyrosine kinase inhibitor showed promise in animal models of PAH and several case reports
demonstrated cures of PAH with imatinib. A Phase III clinical trial of imatinib in PAH showed marked
improvement in exercise capacity in some patients but did not receive FDA approval because the drug was not
well tolerated. We sought to understand novel mechanisms of imatinib effect in PAH. In preliminary data, we
administered imatinib to mice that express a human mutation that is known to cause heritable forms of PAH
(bone morphogenetic receptor type 2, BMPR2) and tested changes in plasma proteomics as a novel way of
detecting key drug effects in a manner that could be translated to humans and may lend mechanistic insight.
imatinib altered several proteins in the plasma with Friend leukemia virus integration 1 (Fli1) being the most
significantly changed protein. Fli1 is a transcription factor whose function is increased after c-Abl engagement
by imatinib. Interestingly, Fli1 deficiency is well described to play a role in the vasculopathy of the skin of
patients with scleroderma, a condition closely associated with PAH. it is unknown if Fli1 deficiency plays a role
in PAH however. We have used imatinib as a tool to understand mechanisms of pulmonary vascular
dysfunction in PAH and uncovered that Fli1 may play a key role. Our overarching hypothesis is that Fli1
deficiency contributes to PAH development through disruption of endothelial barrier function and that
restoration of Fli1 will restore endothelial function and improve PAH. We propose the following aims to
test this hypothesis: Aim 1. Test the hypothesis endothelial barrier function is impaired in PAH and that
increased Fli1 expression through imatinib exposure restores endothelial function in PAH. We will use
cultured BMPR2 or control endothelial cells with and without imatinib and/or Fli1 siRNA to test barrier function
and the role of Fli1 in regulating endothelial barrier function. Aim 2. Test the hypothesis that Fli1 deficiency
is a rodent model of PAH, enhances pulmonary vascular disease in a rodent model of PAH and that
Fli1 overexpression prevents rodent PAH. This aim will generate two mouse models: inducible global Fli1
knockout and inducible global overexpression of Fli1. We will determine these models exacerbate or improve
an accepted rodent PAH model, Sugen+Hypoxia, and test for pulmonary vascular leak in these models. This
proposal will generate necessary tools to study the role of FLI1 in PAH. In the long term, this work will develop
novel, well-tolerated disease modifying therapies for this rare and highly morbid disease.

Public health relevance
In the short-term, this proposal will develop tools to study Fli1 in pulmonary arterial hypertension and perform experiments demonstrating a potential role for Fli1 in pulmonary arterial hypertension pathogenesis that will serve as preliminary data for future grant submissions. The long-term goals of this work are to develop novel, effective and well-tolerated disease modifying therapies for this rare and highly morbid disease.